Dyn-omics

The overall goal of the Dynomics Project is to provide a molecular genomic 'fingerprint' ofthe genome and transcriptome of cancer cells at all stages of development that can serve as a platform for identify patterns or relationships between physical, morphological, and genomic parameters and correlate those properties with the stage or evolution of the disease in a patient. The samples that we will utilize will match those used in RP1 and RP2 such that the

Public health relevance
The genomic and transcriptomic data set to be generated across space in tumor tissue and in time from circulating tumor cells will provide a dynamic parameterization of two distinct forms of cancer, colon and lung. The integration of these data sets into a physical modeling framework will provide unique insights into the physical dynamics of cancer progression.